SELENOF is a Novel Tumor Suppressor and a New Target to Overcome Racial Disparity in Breast Cancer.

Project Summary / Abstract
This proposal addresses the challenge of closing the racial disparity gap in breast cancer mortality by identifying
a contributing biological factor and developing therapeutic strategies to overcome its impact. The selenoprotein,
SELENOF, was recently identified as a new tumor suppressor in breast cancer. The broad hypothesis is that
lower SELENOF levels in African American patients contribute to the racial disparity in breast cancer mortality
by driving tumor progression and poor patient outcome. Therefore, therapeutic strategies to mitigate its loss are
needed to help close the disparity gap. The scientific premise for the hypothesis is based on the following: 1) the
genomes of breast tumors from African Americans have a 5-10 fold higher frequency of SELENOF single
nucleotide polymorphisms (SNPs), which account for lower SELENOF protein levels, 2) SELENOF mRNA
expression is significantly lower in breast tumors from African American patients compared to Caucasians, and
lower SELENOF levels predict shorter survival in these patients, 3) loss of SELENOF in normal breast epithelial
cells resulted in increased proliferation and abrogated cell death, features of cellular transformation, and 4)
overexpression of SELENOF in breast cancer cells induced cell death, blocked proliferation and survival,
enhanced response to therapies, and inhibited tumor growth in vivo. The eukaryotic initiation factor 4a3 (eIF4a3)
was identified as a translational repressor of SELENOF. The SELENOF locus SNPs are predicted to enhance
eIF4a3’s binding affinity resulting in stronger repression of SELENOF translation. Preliminary data showed that
pharmacologic inhibition of eIF4a3 results in increased SELENOF protein levels and reduced breast cancer cell
viability in a SELENOF-dependent manner. Loss of SELENOF also resulted in hyperactivation of the
kinase/RNase inositol-requiring enzyme 1 (IRE1), a master regulator of the unfolded protein response. This
rendered cells highly susceptible to IRE1 inhibition, thus identifying a new vulnerability in these cells. Four aims
are proposed: 1) Determine the mechanisms underlying SELENOF-induced cell fate in breast cancer, 2)
Determine whether loss of SELENOF drives tumorigenesis by using African American derived xenografts and a
murine model of breast cancer, 3) Determine the impact of SNPs on the regulation of SELENOF translation by
eIF4a3, and 4) Determine whether eIF4a3 overexpression and the SNPs contribute to reduced SELENOF tumor
levels and poor outcome in African American breast cancer patients. Our work will establish SELENOF as a new
target to reduce racial disparity in breast cancer, and thus support the development of SELENOF-based
therapies. In the clinic, SELENOF’s SNPs and levels can also serve as candidate biomarkers to identify African
American patients at risk of aggressive disease. The distinct therapeutic strategies investigated here are likely
to result in novel and more effective personalized medicine and may help close the disparity gap.

Public health relevance
Project Narrative This work will establish that reduction in SELENOF levels is an underlying biological factor contributing to racial disparity in breast cancer, and thus supports the development of SELENOF-based therapeutics. Successful completion of pre-clinical studies on two different therapeutic strategies investigated here may result in personalized and more effective therapy options for African American patients affected by low SELENOF. SELENOF polymorphisms and protein levels can be developed into biomarkers to identify African American patients at risk of lethal breast cancer disease.